Cancer Research Training & Education Coordination

PROJECT SUMMARY
CANCER RESEARCH TRAINING & EDUCATION COORDINATION
Cancer Research Training & Education Coordination (CRTEC) at Moffitt Cancer Center (Moffitt) comprises 30+ distinct research education and training opportunities that engaged more than 5,700 research, clinical, and oncology health professional students, trainees, and faculty since 2016. These activities highly impact each of the five research Programs and span the education continuum, from primary school students to faculty, and throughout all scientific disciplines. CRTEC’s overarching goal is to foster the best talent across the spectrum of cancer researchers and oncology professionals. Strategic focus areas are developing advanced support for fellowship and training grant submissions, enhancing recruitment at all career stages, expanding educational integration in the catchment area, and supporting new initiatives through four Specific Aims:
Aim 1: To coordinate educational operations and multi-institutional collaborations.
Aim 2: To expand the tracking of all trainees and education activities.
Aim 3: To facilitate career mentorship and career development activities that enable trainees and faculty to maximize their career potential.
Aim 4: To expand the biomedical career development pipeline through internal and external education, peer networking, and proactive recruitment.
CRTEC is a key area of the Research Strategic Plan, evidenced by consolidation of the educational structure into two integrated offices, Research Education & Training (RET) and Office of Clinical Education (OCE), under the ACD of Research Education & Training. Together, the RET/OCE offices coordinate all educational activities of the Center, facilitating the integration and synergy of education. The Center provides over $14 million annually to support CRTEC efforts. Peer-reviewed funding for training grants increased the from $2.0M last cycle $2.4M including 3 NCI T32, 1 F, 6 K, and 2 R25 awards. A majority of K-12 and undergraduate trainees are from the catchment area with 47% from underserved populations, while PhD trainees, fellows, and faculty are from around the world. Former trainees are now leaders in cancer research and clinical care, including 29 faculty who matriculated from our T32, K, and PhD programs. We also established three novel PhD majors (Cancer Immunology & Immunotherapy, Cancer Chemical Biology, Integrated Mathematical Oncology), enhanced fellow training, created an Instructor level to advance senior fellows into faculty, doubled our K grant portfolio, and established strong mentoring programs for all junior faculty. Finally, integrated efforts with the Community Outreach & Engagement Office has further expanded our activities into the community, by providing STEM exposure to children, parents, and teachers.